Discerning the role of semaphorin 7a in mammary tumor growth and anti-tumor immunity

Project
Early
the
years
childbirth,
These
vessels.
are
7a —a signaling molecule that activates integrin-β1 signaling in cancer—is upregulated in PPBC and
is associated with increased LVD, TAMs, and metastasis. Additionally, SEMA7A+ tumors recapitulate the
accelerated tumorigenesis and metastatic profiles observed in PPBC and high SEMA7A expression correlates
with decreased overall survival. As such, PPBCs likely only represent a subset of SEMA7A+ cancers; there are
Summary/Abstract
detection and reatment of breast cancer (BC) has reduced the number of BC-related deaths but remains
leading cause of cancer-related death in women ages 15-54. Over half of all BCs diagnosed i n women <40
of age fit the definition of postpartum breast cancer (PPBC), BCs diagnosed within 10 years of last
which are 2-3 times more likely to metastasize compared to BCs diagnosed in nulliparous patients.
deaths are generally attributed to dissemination of tumor cells to distant tissues via blood and lymphatic
Increased lymphatic vessel density (LVD), ymphovascular invasion, and lymph node positivity (LN+)
frequently observed in PPBC and are associated with worse prognosis. We have identified that semaphorin
(SEMA7A)
t
l
currently no therapies targeting SEMA7A.
to
Tumor-associated
(TME).
prognosis
SEMA7A+ BCs exemplify four key hallmarks of cancer: 1) resistance
cell death, 2) angiogenesis and lymphangiogenesis, 3) immune evasion, and 4) invasion and metastasis.
macrophages (TAMs) are i mplicated in each and in creating a pro-tumor microenvironment
As TAMs and LVD are amplified in SEMA7A+ BC, it is probable that they contribute to the worse
of PPBC. SEMA7A can also polarize macrophages into a subset of TAMs (termed “PoEMs”) that
express lymphatic-associated proteins. These PoEMs intercalate into lymphatic vessels to form PoEM-LEC
chimeric vessels and tumor cells associate with these vessels at PoEM-LEC junctions, which may mediate tumor
cell escape. Moreover, SEMA7A can promote expression of PD-L1-expression on BC cells, LECs, TAMs, and
PoEMs to suppress anti-tumor immunity; however, additional effects of SEMA7A on immune cells of the TME
have not been investigated. Altogether, this led us to the hypothesis that SEMA7A activates pro-survival
signaling in immunosuppressive PoEMs to promote tumor cell dissemination.
Thegoals of thisproposal are to: 1) determine the mechanisms by which SEMA7A induces cell survival
and alters the immune TME to a pro-tumor state, and 2) investigate the chemoattractants produced by PoEMs
that recruit tumor cells to PoEM-LEC junctions and promote metastasis. In aim 1, we will define the mechanisms
of SEMA7A-induced cell survival and effects on immune cells of the TME. We will also establish whether
monoclonal antibody-induced inhibition of SEMA7A impedes tumor growth and immune suppression. In aim 2,
we will define chemoattractants that recruit tumor cells to PoEM-LEC junctions. The results of these studies will
identify how SEMA7A promotes tumor progression, immunosuppression, and lymphatic-meditated metastasis,
as well as offer insight for future therapies to target SEMA7A+ BCs, thus improving survival for many BC patients.

Public health relevance
Project Narrative We have shown that SEMA7A promotes multiple aspects of breast cancer progression, including proliferation, survival, invasion, and immune evasion. This proposal aims to define the mechanisms by which SEMA7A induces pro-survival signaling in tumor-adjacent cells of the TME to suppress anti-tumor immunity while also promoting tumor cell dissemination via lymphatics. Understanding these mechanisms may reveal novel targets for the treatment of SEMA7A+ breast cancers and/or lymphatic-mediated metastases.